Administration Core

Abstract (Core A)
Core A functions to provide the leadership, interaction and coordination between the different projects of the
Program Project Grant (PPG) in order to help them meet their scientific goals. Core A will work to ensure: (1)
that robust and timely statistical support is provided to all projects and Core B, (2) that the resources of the PPG
are distributed fairly among the projects, (3) that the regulations of the National Cancer Institute (NCI) are fulfilled,
and (4) that technical support for hardware and software is supplied. It can be divided into two sections: scientific
support and administrative support.
Support for biostatistics and bioinformatics is crucial for study design and data interpretation; thus it is an
important scientific function of Core A. A large team of highly experienced biostatisticians and bioinformaticians
(Ying Lu, Ph.D., Rie vonEyben, M.S., Andre Shultz, Ph.D., and Subarna Sinha, Ph.D.) will provide the needed
statistical support to all PPG members. In addition, Dr. Lu, who is the co-director of the Stanford Cancer Institute
Biostatistics Core, is able to mobilize additional statistical support from this larger core to assist the PPG as
needed. Other important functions of the scientific support will be: (1) to organize and hold regular meetings of
the project/ core leaders and key personnel, (2) to convene Executive Committee meetings to review the
progress and scientific direction of the grant, and (3) to organize an annual retreat with the members of the
External Advisory Board (EAB) to review the progress of the PPG as a whole. Mr. Frank Chavez will act as the
Administrative Coordinator of this PPG. He is currently the research program manager in the Department of
Radiation Oncology and has been working closely with the principal investigators (PIs), project and core leaders
in the preparation of the grant application. He has also been coordinating their bi-weekly meetings/ calls in the
last year. Mr. Eric Alemany will provide the technical support for all software and hardware problems and
questions. He has served in this role for 10 years in a previous PPG within the department and therefore is
familiar with the needed IT support and infrastructure. The administrative core will also be responsible for
submitting the yearly PPG progress report to the NCI, including the written report of the EAB.
An important aspect of administrative support will be to monitor the dispersion of financial resources and research
allocations. The PPG Executive Committee, which is composed of all four project leaders will meet twice a year to
review expenditures and resource allocations for the projects and cores. Ms. Joyce Chao, who has been a
finance analyst in the Department of Radiation Oncology for the past 6 years, will serve as the financial
administrator for this proposed PPG.
An additional function of the administrative core will be to disseminate information on Stanford seminars that are
broadly related to the scientific directions of the PPG. A final aspect of the scientific support will be to ensure that
all investigators are using common reagents to maintain uniformity in animal and experimental protocols.

Public health relevance
Narrative (Core A) The success of a Program Project Grant involves statistical assistance, fiscal support, administrative management, and coordination between the projects and cores. In addition, the increased administrative requirements have driven the need for an administrative core. This core will work to ensure that all project and core leaders have adequate support and time to focus on their science.